Oklahoma Center of Medical Imaging for Translational Cancer Research

Oklahoma Center of Medical Imaging for Translational Cancer Research
Abstract – Overall Component
In order to highly align with the Strategic Plan of the University of Oklahoma (OU) to create the
multidisciplinary Research Centers of Excellent in one of the primary research themes namely, the future of
health, the overarching objective of this COBRE application is to establish a new medical imaging center for
conducting the translational cancer research by leveraging the established research supporting resource and
collaboration network between the biomedical engineering and clinical research in OU. This COBRE will provide
research infrastructure along with the multidisciplinary leadership and mentoring teams to support the promising
research project leaders (RPLs) of the junior investigators as they establish independent research careers. An
essential component will be providing support for innovative research projects that develop and apply novel
medical imaging technology and quantitative imaging predictive markers to translational cancer research. The
success of these research projects will make impact and contribution to the future of health including the advance
of the precision medicine to significantly improve efficacy of the personalized cancer risk prediction, screening,
diagnosis and treatment. Since 2012, OU has developed and established a collaborative network and diverse
portfolio of research projects that bridge the biomedical imaging engineering faculty in the Gallogly College of
Engineering (GCoE) with the physician scientists or clinical researchers in the Stephenson Cancer Center (SCC).
Building on our experience in conducting joint translational cancer research using medical imaging technology,
this COBRE aims to support and further develop this collaborative research infrastructure between the GCoE
and SCC to enhance the research capability and progress of the RPLs as they further develop the team-based
and translational research projects. In order to promote the translational research projects with potentially high
clinical impact and significance, this COBRE will include the RPLs with both biomedical imaging engineering and
clinical research training backgrounds. Each RPL will also have two senior mentors with expertise in biomedical
engineering and clinical research, respectively, to further enhance the collaborative research approach. In
summary, in order to enhance the medical imaging related translational cancer research capacity in OU and
ensure RPLs to establish independent research careers, we propose the following three Specific Aims in this
COBRE: (1) to implement a dedicated program for mentoring RPLs in their proposed research projects and
enabling them to become independent researchers with non-IDeA external research support; (2) to strengthen
and develop new research infrastructure and shared resources to support current and future medical imaging
related translational cancer research projects; and (3) to foster and enhance the multidisciplinary collaborative
research activities between the biomedical engineering faculty and physician scientists or clinical researchers to
facilitate the outstanding translational medical imaging related cancer research projects.

Public health relevance
Overall Significance to Public Health (Project Narrative) The overarching objective of this COBRE application is to establish a new biomedical imaging research center with appropriate infrastructure and research capacity along with a multidisciplinary mentoring team to support the promising research project leaders of junior investigators as they conduct the innovative translational cancer research projects using advanced medical imaging technology. The success of this COBRE will ultimately have a high research and clinical impact lead to a reduced cancer burden both for individual patients and society as a whole.